A Biobased Biodegradable Sunscreen that is Safe, Removes Environmental Impact, is Inclusive of all Skin Tones, and is for the Purpose of Eliminating Disparities in Melanoma Mortality Rates

Project Abstract/Summary
Over 9000 people die of Melanoma in the United States every year [1]. It is the most
common skin cancer. However, not all are affected equally. While white patients have a
higher incidence rate, patients of color have a significantly higher fatality rate once
melanoma develops [2]. Even the darkest skin tones with the greatest amount of
melanin are not protected from ultraviolet (UV) radiation. DNA damage from UV light
can be measured in all skin types and all skin types may develop melanoma from DNA
damage [3]. While chemical sunscreens have made progress toward removing
aesthetic concerns, these chemicals can enter the bloodstream with uncertain health
effects. Physical sunscreens based on ZnO/TiO2 do not have the same risk, however
the white/”ashy” appearance on darker skin limits their adoption.
This proposal is for the development of a physical sunscreen based on the non-toxic,
biocompatible, and naturally occurring polyester poly-3-hydroxybutyrate (PHB) that is by
nature less whitening than physical sunscreens on the market, allowing for greater
adoption by individuals with darker skin. PHB is part of the natural carbon cycle and
readily biodegrades in marine environments. Light transmission through PHB’s crystal
structure increases with increasing wavelength; PHB blocks up to much more UV light
than visible light, giving it a less white appearance than minerals that reflect visible light.
The specific aims of this proposal are to: 1) Produce and isolate PHB for sunscreen
formulation; 2) Obtain a range of particle and crystal spherulite sizes by varying spray
drying/annealing parameters; and 3) to study the effects of particle size and spherulite
size on UV light transmission and sensory acceptance (specifically grittiness).
It is important to design sunscreen products that address the tone issues while limiting
uncertain health/environmental risks. Making sunscreen that is inclusive of all skin tones
will help increase application to all ethnicities equally and will help lessen the health gap
by reducing the mortality rate of people of color who develop melanoma. Our innovation
will address these issues and is superior to other sunscreens. Our innovative sunscreen
is designed to be (1) bio-based and biodegradable making it (2) a safe and healthy
option, (3) that doesn’t have a perceivable tone on any skin color, and (4) has removes
the negative environmental impact that is associated with many sunscreens on the
market today.

Public health relevance
Project Narrative Due to bias in the sunscreen industry, there is unequal application of sunscreen in light and dark-skinned communities and ultimately this has helped result in a much higher mortality rate for dark-skinned individuals who develop melanoma. As an additional deterrent, most sunscreen products are made of physical blockers that make darker skins appear ashy, and sunscreens that don’t are typically chemical based where there is considerable concern around the safety of these chemicals both for human health and the health of natural environments. We are developing a physical sunscreen based on the naturally occurring, non-toxic, biodegradable microbial polyester poly-beta-hydroxybutyrate that is far less whitening than physical sunscreens on the market today.